Core A: Administration

Core A: Project Summary
The Administrative Core (Core A) will function as a central coordinating unit of this PO1 Program and its main
charge will be to develop and execute the collaborative initiatives among different components and integrate
the programmatic activities, manage the administrative, financial and compliance matters, and communicate
with the scientific advisory and regulatory authorities. Dr. Xue-Ru Wu, the Principal Investigator of this PO1
Program, with the assistance of a part-time Program Coordinator, Ms. Jessica O'Halloran, will manage the
daily operation of this Core. The small operating budget will allow Dr. Wu to manage, in a highly efficient and
cost-effective manner, the scientific, budgetary and administrative matters of this PO1 Program. The Specific
Aims of the Core are to: ensure the sustained thematic focus of this PO1; launch, coordinate and implement
the collaborative initiatives; integrate the scientific activities and resources; assess the overall conduct and
progress of the entire program and each component Project and Core; apply for and renew protocols for
animal, biosafety and recombinant DNA studies; communicate with the institutional Sponsored Program
Administration (SPA) and National Cancer Institute; report to and seek advice from the Advisory Committee;
organize monthly Project Directors' meetings, seminars and research conferences; and prioritize program
resources and resolve potential conflicts.